The Effect of WTC Exposure on Thyroid Cancer in the Survivor Population

Project Summary
The reported two-fold excess risk of thyroid cancer in multiple World Trade Center (WTC) cohorts
is not solely explained by overdiagnosis due to surveillance or physician bias. Endocrine
disruptors (EDs), known to disrupt thyroid function and associated with thyroid carcinogenesis
and cancer aggressiveness, have been found in WC dust samples. WTC dust-associated EDs’
exposure may potentially be associated with thyroid carcinogenesis and thyroid cancer
aggressiveness via multiple pathways, in particular in children and adolescents exposed to the
WTC dust during these critical developmental windows.
Thyroid cancer in the WTC survivors’ population is largely unstudied and no study to date has
investigated the potential impact of early life exposure to the WTC dust cloud on thyroid
carcinogenesis and cancer aggressiveness. Using the WTC Environmental Health Center
survivor population, including individuals who were <18 years at the time of WTC exposure, we
aim to investigate the clinical, mutational, pathological, and inflammatory thyroid cancer profiles,
hypothesizing that (early life) WTC exposure is associated with more aggressive thyroid cancer.
First, we will perform an in-depth assessment comparing the clinical and mutational
characteristics of WTC thyroid cancer to non-exposed controls (aim 1). Additionally, we will
compare WTC thyroid cancer cases in the survivor population with unexposed control cancer
cases to investigate the pathological features using computational modelling approaches (aim 2)
and the gene expression profiles using Spatial Gene Expression (aim 3). We will perform a
subgroup analysis of the individuals < 18 years at the time of WTC exposure.
This study would be the first in-depth study to investigate thyroid cancer in the WTC survivor
population, including an assessment of thyroid cancer in patients exposed as children or
adolescents, integreting novel techniques including computational pathology modelling and
Spatial Gene Expression. The proposed methods can easily be transposed to other solid cancers
with increased risk in the WTC survivor population and to other environmentally exposed
populations with increased cancer risk. Furthermore, identifying phenotypes and biomarkers
associated with increased risk of more aggressive thyroid cancer will help identify patients
needing more aggressive thyroid cancer screening and management and may lead to more
effective health care delivery for this population.

Public health relevance
Project narrative The excess cancer risk in the World Trade Center (WTC) cohorts is not solely explained by surveillance or physician bias thus excess thyroid cancer and possibly more aggressive thyroid cancer may be due to exposure to endocrine disruptors present in WTC dust. Thyroid cancer is largely unstudied in the WTC survivor population which includes adolescents and minor children even though it is well documented that childhood / adolescence exposure to endocrine disruptors is significantly associated with thyroid carcinogenesis. Identifying phenotypes and biomarkers associated with increased risk of more aggressive thyroid cancer in WTC survivors, particularly those < 18 years when exposed, will help identify patients needing more aggressive thyroid cancer screening and management, lead to more effective health care delivery for this population, and shape future studies investigating cancers with excess risk in the WTC and other environmentally exposed populations.